Mechanisms of TIMP2-mediated hippocampal revitalization in Alzheimer's disease

Project Summary/Abstract: Given that aging is the major risk factor for many neurological disorders,
including devastating diseases for which there is no cure like Alzheimer’s disease, novel approaches are
needed to confront the growing epidemic. Many studies have shown that factors present within the systemic
environment regulate markers of brain aging in a bidirectional (young or old) fashion, which led me to search
for specific protein activities that could mediate key phenotypes. One such factor we have focused on in our
funded parent grant is tissue inhibitor of metalloproteinases 2 (TIMP2), which we have shown is sufficient to
improve learning and memory and is a key component of very young human plasma for mediating improved
hippocampal function. Moreover, several studies implicate TIMP2 in relation to risk for Alzheimer’s disease,
though the mechanism underlying this relationship (e.g., amyloid-dependent vs. amyloid-independent
processes) remains unclear. We demonstrate that expression of TIMP2 is critical for cellular homeostasis and
function within the hippocampus, including within glia and for the process of adult neurogenesis. Differential
gene expression data in mice lacking TIMP2 indicate that various cellular processes in neural cells are
disrupted. We hypothesize that specific aspects of intercellular communication among cells of the hippocampal
microenvironment is regulated by TIMP2 and in a manner that regulates Alzheimer’s disease pathology, a
finding that may be dependent on the source of TIMP2. We will address this hypothesis in 2 aims: (1) To
address the cell type-specific regulation of TIMP2 within the hippocampus via snRNAseq and the impact of the
source of its expression on cellular interactions. (2) To address the cell type-specific regulation of TIMP2 within
the hippocampus in the context of amyloid and associated AD pathology in APP-knockin mice via snRNAseq
and the impact of the source of its expression on cellular interactions. These aims will examine regulation of
the CNS cellular microenvironment by TIMP2, which may have implications for development of novel AD
therapies.

Public health relevance
Project Narrative: Though aging is the strongest risk factor for Alzheimer’s disease, we do not yet understand the mechanisms that account for this association at the levels of cellular and molecular processes. Our administrative supplement proposal will probe how TIMP2 regulates molecular pathways across neural cell types within the hippocampus in the absence or present of Alzheimer’s pathology through use of next- generation gene expression analyses. Addressing these aims will significantly deepen our understanding of how age-associated plasticity factors like TIMP2 regulate the hippocampal cellular microenvironment to inform novel treatments for Alzheimer’s disease.